2024 Sensory Transduction in Microorganisms Gordon Research Conference and Gordon Research Seminar

Project summary
The 2024 Gordon Research Conference on Sensory Transduction in Microorganisms to be held in Ventura CA
in January 2024 will explore recent advances in understanding signal transduction in bacteria, especially in
pathogenic bacteria. Focus will be placed on bacteria-host interactions, chemosensory mechanisms and
pathways, two-component regulatory systems, second messenger signaling, metabolic signaling in microbial
communities including biofilms and microbiomes, bacterial defense systems, and bacterial stress responses,
including the coordination of subcellular processes. The roles of these systems with respect to pathogenesis,
antimicrobial resistance, and bioengineering will be central themes. All these critical areas will be addressed
through cutting-edge applications of molecular genetics, cell biology, biochemistry, and chemical biology as
well as structural, imaging, biophysical, and computational approaches. Data from high-resolution experiments
will be paired with modeling to understand and predict the behavior of complex macromolecular assemblies
and signaling circuitry. Invited speakers will include both established and early-stage investigators using a wide
array of approaches. In addition, short talks will be chosen from the abstracts to give additional early-career
scientists a chance to speak and to round on the program. Participants will benefit from the Conference’s open,
collegial atmosphere that provides multiple opportunities to engage in scientific discussion, promote scientific
rigor, and foster interdisciplinary collaboration. New, innovative efforts will be used to increase participation of
scientists from historically under-represented backgrounds, and multiple efforts will be taken to make
participants feel welcome and valued. For the sixth time, a Gordon Research Seminar (GRS) for postdocs and
graduate students will precede the GRC. The GRS provides a supportive environment for young scientists to
present their work, make connections, and receive advice by leaders in the field. The STIM community has
long supported junior scientists, and we view the success of the GRS as a necessity to continue on this
mission. The GRS will help us not only nurture the development of early stage investigators, but also promote
diversity within our community. The GRS will help junior scientists gain the confidence and skills to become
full-fledged GRC participants. The well-integrated STIM GRC/GRS will direct established investigators to the
most important questions confronting our field and will encourage young scientists to apply their recent training
to the exciting new areas of microbiology.

Public health relevance
Narrative Sensory and signal transduction processes are essential for bacterial pathogens to produce virulence factors, to resist antimicrobials, to invade host tissues, and to evade the immune system. The 2024 STIM GRC will gather researchers from diverse fields to understand how bacteria sense and respond to their environment at levels that range from molecular mechanisms to interactions with the host on organismal level. The meeting will provide a powerful collaborative platform to address these questions from different perspectives, which will inform new strategies to develop antimicrobials and to combat infectious diseases.